Administrative Core

PROJECT SUMMARY
The Administrative Core (AC) supports the mission, scientific vision and objectives of the Southern California
Superfund Research and Training Program for PFAS Assessment, Remediation and Prevention Center
(ShARP). The overall goal of ShARP is to develop a problem-based, solution-oriented PFAS research and
training program applicable to contaminated water supplies from Superfund sites and other sources across the
US. The AC provides leadership and administrative support to promote scientific collaboration and to coordinate
research translation across the four Research Projects and four cross-cutting Cores. The AC is led by the ShARP
director, two deputy directors, one of whom is the Research Translation Coordinator (RTC), and the AC
coordinator providing administrative support. The AC and its RTC facilitate dissemination and communication
within the AC and ShARP and with other Superfund Research Programs (SRP), SRP staff, local partners and
with government, industry, and the public. Specific aim (SA) 1: Provide leadership and infrastructure for scientific
and administrative needs of ShARP, promoting a vision of collaborative cross-disciplinary systems
science within- and between SRPs. Working groups, seminars, and other enrichment activities, and a yearly
symposium, facilitate this aim. Robust local engagement and training programs across ShARP are coordinated
with the CEC and with RETTC, respectively. AC coordinated Committees provide advice and guidance; an
External Advisory Committee additionally provides a yearly ShARP evaluation. SA2: Promote bidirectional
partnerships with ShARP partners in government agencies. The AC has coordinated with projects and cores to
establish collaborations with Federal and California state EPA at multiple levels, ATSDR, LA County Department
of Health, state and local water districts, among others. Primary vehicles for this engagement include working
groups, quarterly ShARP investigators meeting and other enrichment activities. SA3: Promote technology
transfer. The AC will engage end users through web-friendly tools with potential to assess mobilization of PFAS
from Superfund sites into aquifers; destroy PFAS in Superfund affected water; improve risk assessment; and
move biomarker discovery into clinical or other applications. Industry partners have opportunities to develop
applications of ShARP research, for example with Small Business Innovation and Technology Transfer Research
grants. SA 4: Disseminate ShARP findings widely to other end-users of SRP research. The RTC will support
investigators in promoting ShARP Center findings through strategic science communication tools, including
media engagement, opinion editorials, and accessible research summaries aligned with Superfund priorities. In
coordination with the RETCC and the CEC, the RTC will assist in the development of user-friendly platforms to
share results with scientific, regulatory, and Superfund-related audiences. Additionally, the RTC will coordinate
with the CEC to organize research-focused briefings and outreach sessions to promote multidirectional
communication with local partners and support the Center’s translational mission.

Public health relevance
ADMINISTRATIVE CORE (AC): PROJECT NARRATIVE The Administrative Core (AC) will facilitate collaboration and dissemination of Superfund-relevant research across the four research projects and 4 cores of the Center, other Superfund Research Programs (SRPs), SRP staff, and with industry, government, key stakeholders and the public. A key focus will be on translating science to support communication and collaboration among SRP end-users. Planned research also has real world application to predicting mobilization of PFAS into aquifers from Superfund-affected sites, destruction of PFAS in Superfund affected water, and improvement in evaluation of PFAS health risks.